Longitudinal Investigation of Factors Impacting the Development and Rehabilitation of Phonotrauma

PROJECT SUMMARY / ABSTRACT
Voice behavior in daily life is assumed to be a primary factor in the development and persistence of phonotrauma
(e.g., vocal fold nodules, polyps, etc.), which is one of the most prevalent behavioral voice disorders. The
shortage of prospective, longitudinal investigations into the ambulatory voice behaviors in high-risk individuals
limits the differentiation between factors that are causative versus compensatory to phonotrauma, and therefore
impacts optimal risk-assessment, mitigation, and therapeutic decision-making. Recent work has found that
individuals with phonotrauma had higher levels of personality traits related to social dominance and impulsivity
and higher speaking vocal doses and increased speaking vocal intensity during voice use in daily life. Individuals
without current vocal pathology had strong relationships between those same personality traits and vocal
behaviors, suggesting that personality traits and speaking voice use in daily life could be robust factors in the
development of phonotrauma and could play a role in the prognosis for recovery. The primary objective of this
project is to determine the enduring role that personality traits and daily voice use have on the development of
phonotrauma, changes in vocal fold kinematics, and on the ability to change damaging vocal behavior using
prospective, longitudinal methods. Aim 1 seeks to identify personality and vocal behavior factors involved in the
development of phonotrauma. This will be achieved through initial assessment using a personality trait inventory,
ambulatory voice monitoring, and laryngeal assessment via high-speed videoendoscopy of vocally
asymptomatic singers who are freshmen in a college voice concentration music program. We will conduct these
assessment procedures bi-annually, beginning in the singer’s freshman year and ending at the conclusion of
their junior year. Aim 2 will assess which ambulatory and vocal fold kinematic parameters are the most predictive
of phonotrauma. Aim 3 will investigate the impact that personality has on compliance with therapeutic/behavioral
recommendations in daily life through personality assessment and ambulatory monitoring before and after
participation in voice therapy. These studies will be the first to use ambulatory monitoring to (1) prospectively
observe factors related to the development of phonotrauma and (2) measure the impact that personality traits
have on the ability to change individual vocal behaviors. It will also be the first to use high-speed videoendoscopy
to observe development of phonotrauma over time. This project will support advancement of the PI’s long-term
career objective, which is to implement a program that uses psychosocial and behavioral factors to improve the
prevention and treatment of phonotrauma in high-risk populations. This career objective can only be achieved
with adequate training in longitudinal research methods, advanced statistical analyses, and acquisition and
analysis of high-speed videoendoscopy. Results from this study will build a framework to ultimately improve early
identification of phonotrauma risk, develop risk mitigation strategies, and inform treatment approaches.

Public health relevance
PROJECT NARRATIVE As one of the most prevalent behavioral voice disorders, phonotrauma (e.g., vocal fold nodules, polyps, etc.) can have devastating impacts on an individual’s ability to function in their daily life, but it continues to be unclear what factors cause and/or perpetuate these disorders. Thus, it is vital to determine factors related to the development and recovery of phonotrauma in order to prevent and adequately treat these disorders. The goal of this research is to longitudinally assess the role that psychosocial and behavioral factors play in the development and persistence of phonotrauma in a group of high-risk individuals with the long-term objectives of improving early identification of individuals at risk for phonotrauma and reforming treatment paradigms to improve outcomes.